Project 1

PROJECT ABSTRACT - PROJECT 1
The induction of immune memory is the basis of vaccination, which arguably is the single most impactful medical
intervention in human history. Nonetheless, vaccines generally have been less effective against respiratory viral
infections. Indeed, the protection offered by currently licensed vaccines against the rapidly evolving respiratory
viral pathogens influenza and SARS-CoV-2 is limited in breadth and short-lived in duration. These shortcomings
have necessitated annual (or more frequent) booster immunizations against these viruses. There is an urgent
need to understand the unique immunological challenges faced by these vaccines to be able to enhance their
protective capacity and durability. Specifically, key knowledge gaps remain with respect to the clonal and
functional dynamics of the germinal center (GC) response over time, and how these dynamics impact the
durability, breadth, and ultimately the protective capacity of vaccine induced immune responses. In this Project,
we will utilize cohorts of vaccinated adults with unique matched samples from blood, draining lymph nodes, and
bone marrow and employ stable isotope labeling of proliferating cells to study at the cellular, molecular, and
genetic levels how GC response dynamics impact qualitative and quantitative antibody, B cell, and T cell
responses after influenza virus or SARS-CoV-2 vaccination. These innovative studies will provide new
information on human immune responses and inform design of new vaccines targeting mutable respiratory
pathogens.

Public health relevance
PROJECT NARRATIVE - PROJECT 1 Vaccination-induced adaptive immunity protects against severe disease from SARS-CoV-2 and influenza, but these viruses continue to infect humans because of the limited duration of vaccine-induced immunity, which is exacerbated by viral antigenic drift. In Project 1, we address key gaps in our understanding of the cellular, molecular, and genetic mechanisms governing the generation and maintenance of the immune cells that confer durable immunity and the diversity of viral strains against which they protect.